Regulation of latent stage differentiation through central carbon metabolism and ubiquitination

Project summary
Toxoplasma latently infects approximately 30% of the human population and is refractory to acute stage
therapies. Latent Toxoplasma can act as a reservoir for acute stage reactivation in immunocompromised
individuals and can cause progressive blindness in otherwise healthy individuals. Thus, latent stages are
clinically important, but currently untreatable.
Drug resistance is likely due to changes in the metabolism of latent stages, but what these are remain a complete
mystery. Furthermore, latent Toxoplasma is exposed to different nutritional environments when infecting its
target tissue types – muscle and the central nervous system (CNS) – and the impact this has on Toxoplasma
latency is not understood. We have found that changes in carbon sources, that mimic muscle and CNS trigger
Toxoplasma differentiation into latent forms. We then performed a whole-genome CRISPR screen and identified
select Toxoplasma carbon catabolic enzymes that are required for differentiation and furthermore, identified a
role for ubiquitination in metabolic adaptation and differentiation into latent forms.
These background studies form the basis for developing a comprehensive understanding of Toxoplasma
metabolism during latency and understanding how metabolic rewiring is linked to differentiation through
regulation by ubiquitination. The specific aims of this program are to:
Aim 1: Define the metabolic pathways required for differentiation and persistence of latent Toxoplasma.
We will determine the role of select enzymes (identified in CRISPR screen) required for utilization of carbon
sources that mimic brain and muscle and their impact on differentiation in vitro and in vivo. This will determine
how metabolism of latent and acute stages differs and how this is linked to environmental sensing and
differentiation.
Aim 2: Determine the role of ubiquitination in the regulation of differentiation into latent forms. Define the
composition, biochemical activity and structure of an E3 ubiquitin ligase complex that is important for
differentiation into latent forms, thus determining how ubiquitination regulates differentiation.
Aim 3: Define how ubiquitination regulates metabolism and differentiation into latent forms. We have
identified likely substrates of the E3 ubiquitination machinery and will define their function in regulation of both
metabolism and differentiation.

Public health relevance
Project narrative Latent Toxoplasma (which infects approximately 30% of the human population) are drug resistant and cause disease in the immunocompromised and progressive blindness in otherwise healthy individuals, leaving vulnerable patients without treatment options. Drug refractoriness likely occurs through changes in metabolism, and we show that these are intimately linked with differentiation into latent forms. We will show host nutritional signals activate Toxoplasma differentiation through a parasite metabolic pathway and key ubiquitination machinery, thus revealing how parasites sense environmental cues to activate latency.